Genome Analysis: Data Accuracy, Haplotyping and Mapping

DESCRIPTION (provided by applicant): We propose to develop an array of novel statistical methods for association analysis of functional phenotypes arising from high-throughput sequencing assays in genetics and genomics, specifically data from RNA-seq, ChIP-seq, and DNase-seq assays. Our proposed approach is to treat the number of reads mapping to each base along the genome as a highly-multivariate, but also highly-structured, phenotype. Using methods from signal processing (wavelets), we will develop methods to identify regions of the genome where these phenotypes differ significantly between samples, or groups of samples (e.g. cell types, treatment groups, or genotype classes). In contrast to approaches based on sliding windows, the methods will be capable of identifying differences that occur at multiple different scales. The statistical methods we develop will facilitate both small-scale comparisons (e.g. identifying differences in binding, o histone modifications, between two samples or conditions), and larger-scale analyses, such as genetic association analyses that aim to identify genetic variants associated with these phenotypes (expression QTLs, binding QTLs, dsQTLs). As an important special case, our methods will tackle the commonly- encountered problem of identifying differentially expressed genes, including variations in splicing or alternative transcripts, from RNA-seq data. These methods will build on and substantially extend methods for association analyses developed during the current funding cycle of this R01. The result of our research will be a suite of statistical tools that will greatly facilitate the analysis of the wide range of genetic and genomi studies that involve functional phenotypes. We will produce and distribute user-friendly software implementing these methods. We will use our methods to analyze existing data generated by our collaborators, and publicly-available data from the NIH-funded GTeX project, both to compare them with existing analysis methods and to identify regulatory genetic variants responsible for phenotypic variation. The overall objective is for the work to provide software and statistical tools for the genetics and genomics research community, facilitating biological discoveries and insights, and, ultimately, understanding of the genetic basis of common disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will generate statistical tools for the genetics and genomics research community, and apply them to identify functional genetic variants that affect human phenotypes. These tools will help facilitate biological discoveries and insights, and, ultimately, understanding of the genetic basis of common disease. __SpecificAimsTextDelimiter__ Speci c Aims Overall Objective: We propose to develop an array of novel statistical methods for association analysis of functional phenotypes arising from high-throughput sequencing assays in genetics and genomics, speci cally data from RNA-seq, ChIP-seq, and DNase-seq assays. Our proposed approach is to treat the number of reads mapping to each base along the genome as a highly-multivariate, but also highly-structured, phenotype. Using methods from signal processing (wavelets), we will develop methods to identify regions of the genome where these phenotypes di er signi cantly between samples, or groups of samples (e.g. cell types, treatment groups, or genotype classes). In contrast to approaches based on sliding windows, the methods will be capable of identifying di erences that occur at multiple di erent scales. The statistical methods we develop will facilitate both small-scale comparisons (e.g. identifying di erences in binding, or histone modi cations, between two samples or conditions), and larger-scale analyses, such as genetic association analyses that aim to identify genetic variants associated with these phenotypes (expression QTLs, binding QTLs, dsQTLs). As an important special case, our methods will tackle the commonly-encountered problem of identifying di erentially expressed genes, including variations in splicing or alternative transcripts, from RNA-seq data. These methods will build on and substantially extend methods for association analyses developed during the current funding cycle of this R01. The result of our research will be a suite of statistical tools that will greatly facilitate the analysis of the wide range of genetic and genomic studies that involve functional phenotypes. We will produce and distribute user-friendly software implementing these methods. We will use our methods to analyze existing data generated by our collaborators, and publicly-available data from the NIH-funded GTeX project, both to compare them with existing analysis methods and to identify regulatory genetic variants responsible for phenotypic variation. The overall objective is for the work to provide software and statistical tools for the genetics and genomics research community, facilitating biological discoveries and insights, and, ultimately, understanding of the genetic basis of common disease. Speci c Aims The work will be accomplished by tackling the following Speci c Aims: 1. Develop novel statistical methods for identifying di erences in expression, binding, histone modi cations, or chromatin accessibility, from RNA-seq, ChIP-seq, and DNase-seq assays. The methods will use tools from signal processing, known as wavelets or \multi-scale" methods. They will: a) Perform small sample comparisons (as small as one sample vs one sample) to identify regions in the genome showing signi cant di erences in these assays between two cell types, treatment conditions, etc. b) Perform larger-scale genetic association analyses, to identify SNPs associated with expression, transcription factor binding, histone modi cations, or DNase-hypersensitivity. c) Incorporate information from splice reads in RNA-seq data to better detect splicing di erences between samples or genotype classes. 2. Develop novel statistical methods for joint, multivariate association analysis of multiple functional phenotypes. Speci cally we will develop statistical methods for: a) Joint association analysis of multiple functional phenotypes measured on the same samples. We will develop methods for both i) 2-sample comparisons, and ii) large-scale genetic association analyses. We will apply these methods to DNase-seq and RNA-seq data to distinguish di erent classes of regulatory genetic variants (e.g. those that a ect both chromatin openness and gene expression, vs those that a ect expression only). b) Mapping of QTLs that are associated with a functional phenotype's response to treatment (e.g. a pharmacological treatment). We will apply these methods to RNA- seq data involving treated and untreated samples, with the aim of identifying SNPs whose e ect on expression changes when a treatment is applied; 3. Develop and freely distribute user-friendly software implementing our methods. Fully documented software implementing the methods will be made available via the internet.